FOOD EFFECT ON BIOAVAILABILITY OF NAVELBINE IN SOLID TUMORS AND LYMPHOMAS

This study is to compare the bioavailability of the liquid-filled capsule formulation of NAVELBINE given with and without food. Additional information is being collected on the safety and tumor spectrum of NAVELBINE and the effect of dividing the dose.